Advancing the Science of Mentorship: Future Directions for Sustainable Implementation and Evaluation of Mentorship Education for the Clinical and Translational Science Workforce

RR-7 – PROJECT SUMMARY
Effective mentorship is recognized as critical to the professional development of those engaged in biomedical
research careers, including clinical and translational investigators. The Clinical and Translational Science
Awards (CTSA) Program has recognized that advancing mentorship– including interventions to increase
access to and the quality of mentorship education is key to fostering the growth of a diverse clinical and
translational research workforce. UW-Madison investigators, in partnership with collaborators from other
institutions, including many at other CTSA hubs, have led the development, testing and broad dissemination of
curricula and resources of evidence-based mentorship education. The University of Wisconsin-Madison has
become a national hub for culturally responsive mentorship education and research advancing the science of
mentorship. The overall objective of this proposed conference is to leverage the expertise and resources at
UW-Madison and across the CTSA Consortium to provide an engaging and scholarly forum for clinical and
translational scientists and institutional leaders from across the nation to learn about and contribute to
evidence-based and sustainable approaches to mentorship education that are scalable and culturally
responsive. The conference, Advancing the Science of Mentorship: Future Directions for Sustainable
Implementation and Evaluation of Mentorship Education for the Clinical and Translational Science Workforce
will provide participants with the opportunity to engage with newly tested mentorship education modules,
experiment with innovative mentorship tools, share examples of programmatic structures that support effective
mentorship and model best practices in the effective facilitation of mentorship education.

Public health relevance
RR-8 – PROJECT NARRATIVE The overall objective of the proposed conference Advancing the Science of Mentorship: Future Directions for Sustainable Implementation and Evaluation of Mentorship Education for the Clinical and Translational Science Workforce is to leverage the expertise and resources at UW-Madison and across the Clinical and Translational Science Awards (CTSA) Consortium to provide an engaging and scholarly forum for clinical and translational scientists and institutional leaders from across the nation to learn about and contribute to evidence-based and sustainable approaches to mentorship education that are scalable and culturally responsive. The conference will provide participants with the opportunity to engage with newly tested mentorship education modules, experiment with innovative mentorship tools, share examples of programmatic structures that support effective mentorship and model best practices in the effective facilitation of mentorship education.